Project 3

Project 3 Abstract
Exposures to environmental hazardous substances, including those in the event of natural and
anthropogenic disasters, are known to negatively impact pregnancy, leading to adverse outcomes
such as preterm birth (PTB). However, establishing a clear link between exposure and pregnancy
risk is challenging, due to lack of a mechanistic knowledge by which toxicants activate pathways
causing PTB in maternal-fetal tissues. Unfortunately, current in vitro and in vivo toxicity testing
models are either not sufficient in assessing the hazards of tested substances on pregnancy
outcomes, do not represent the human in utero structure and functions accurately, or are too costly
and low throughput. In addition, assessment of the hazards imposed by exposures to complex
environmental samples that may contain multiple hazardous chemicals, often observed after
disasters, is even more challenging. Here, we propose to develop a feto-maternal (F-M) interface
tissue chip-based testing strategy for assessing the human health hazard of environmental
substances on PTB. Our central hypothesis is that a tissue chip model that mimics the physiology
of the complex multi-cellular F-M interface will enable evaluation of the mechanistic
pathophysiologic pathways affected by exposure to complex environmental hazardous substances
that may increase the risk of PTB. These tissue chip models mimic the fetal and maternal uterine
tissues structurally and functionally, and will be used to evaluate mechanistic pathophysiologic
pathways in the F-M interface imposed by complex mixed environmental hazardous substances.
This will be accomplished through the following three aims. In Aim 1, we will develop a mechanistic
model of PTB in response to environmental toxicants using a fetal membrane tissue chip model. In
Aim 2, we will develop a mechanistic model of PTB in response to environmental toxicants using a
placenta tissue chip model. In Aim 3, which will focus on the application of our novel models for
Disaster Research Response (DR2), we will demonstrate rapid assessment of the potential human
health hazards of environmental exposures on disrupting F-M homeostasis that can lead to PTB
by using a higher-throughput F-M tissue chip model. The success of this proposed research will
provide critical and timely information for hazard assessment on toxicants’ impact on PTB using
tissue chip models, especially related to toxicants from existing Superfund sites and from
emergency disaster-related contaminants. Thematically, this project is well integrated into the
Texas A&M University Superfund Research Center that is focusing on addressing the human health
risks of exposure to hazardous substances during and after emergencies, especially the effects on
particularly susceptible populations (pregnant women and children).

Public health relevance
Project 3 NARRATIVE Exposures to environmental hazardous substances, including those that may be released in the event of natural and anthropogenic disasters, are known to impact pregnancy, leading to adverse pregnancy outcomes like preterm birth. Here, we propose to address our central hypothesis that a tissue chip model mimicking the complex multi-cellular feto-maternal interface can be used to evaluate the mechanistic pathophysiologic pathways related to preterm birth that may be perturbed by complex mixtures of environmental hazardous substances. We will also develop and utilize a higher throughput tissue chip model that can rapidly assess the potential hazard of environmental samples that may lead to preterm birth.